QUALITY ASSURANCE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. To develop a quality assurance program for all of the MR scanners at the Center for In Vivo Microscopy to quantitatively measure any SNR change in the scanners over time using specialized, standardized phantoms. The project will enable troubleshooting of the scanners by creating standardized datasets, which can be compared over time.